Cardiovascular Health of Low-Income Working-Age Adults in the US: Health Care Access, Policy, and the Pandemic

PROJECT SUMMARY/ABSTRACT
In the United States, declines in cardiovascular mortality have stalled, and there is growing concern that these
population-level trends may reflect an increase in the burden of cardiovascular risk factors and disease in low-
income working-age adults (18 to 64 years). However, these patterns have not been well characterized on a
national scale. The COVID-19 pandemic has only magnified the critical need to track the cardiovascular health
of the low-income working-age population. The pandemic has led to substantial disruptions in health care, and
created enormous spillover effects, including unemployment and deepening financial hardship, which have
fallen more heavily on low-income adults. These changes may widen inequities in health insurance coverage,
health care access, and affordability, and ultimately, worsen cardiovascular health for years to come. In the
wake of the pandemic, policymakers are now weighing whether to expand the Medicare program to increase
access to health care. Understanding the potential effects of this policy change on the cardiovascular health of
low-income adults could inform federal strategies to improve health equity nationwide. Building on our team’s
expertise in the linkage and analysis of large datasets, the application of epidemiological and
econometric methods, and the evaluation of health policies, we will examine changes in cardiovascular
risk factors, disease, and outcomes in low-income working-age adults, assess the impact of the
pandemic on health care coverage, access, and affordability as well as cardiovascular morbidity and
mortality, and determine the potential effects of expanding Medicare on the cardiovascular health of
this population. To do so, we will use a unique combination of national survey data, state all-payer and
national Medicaid claims, and CDC epidemiological data. In Aim 1, we will perform a national analysis that
determines whether the prevalence, treatment, and control of cardiovascular risk factors, incidence of acute
cardiovascular events, and cardiovascular mortality were increasing in low-income working-age adults prior to
the pandemic. In Aim 2, we will examine whether the pandemic was associated with short- and long-term
changes in health care coverage, access, and affordability, cardiovascular morbidity and mortality, and self-
reported health in low-income working-age adults using interrupted time series analyses. In Aim 3, we will
evaluate the effects of Medicare on health care access and affordability, the screening, treatment and control
of cardiovascular risk factors, and self-reported health in low-income adults using quasi-experimental
approaches. This research will advance our understanding of changes in cardiovascular morbidity and
mortality among low-income working-age adults, before and after the pandemic, and provide critical insights on
the implications of expanding Medicare on health care access, affordability, and cardiovascular health for this
population. Cardiovascular disease remains the leading cause of death in the US, and our work will ultimately
inform public health and policy strategies to improve cardiovascular outcomes – and equity – nationwide.

Public health relevance
PROJECT NARRATIVE There is mounting concern that the cardiovascular health of working-age adults (18 to 64 years) may be worsening in the United States. We will combine multiple sources of information, including national surveys from the Centers for Disease Control and Prevention, health care data from Medicaid and other insurers, and population-level death data to 1) characterize the epidemiology of cardiovascular risk factors, acute cardiovascular events (heart attack, heart failure, stroke), and cardiovascular deaths in low-income working-age adults on a national scale, 2) evaluate changes in health care coverage, access, and affordability, as well as cardiovascular morbidity and mortality, in the years that follow the Covid-19 pandemic, and 3) determine the potential effects of expanding the Medicare program on the cardiovascular health of this population. This research will provide critical information that informs public health and policy strategies to improve cardiovascular outcomes nationwide.